Brevetoxins and Emergency Encounters among Children (BEECH)

PROJECT SUMMARY
Algal blooms - the rapid growth of photosynthetic organisms in water - endanger human health,
but there is a stunning lack of data regarding effects on children. The algae K. brevis blooms in
the Gulf of Mexico almost annually, causing `red tides' that last for months to years. K. brevis is
fragile, breaking in the surf and releasing potent brevetoxins (natural poisons that are odorless
and tasteless) into the water and marine aerosol that can be carried inland by wind, potentially
being inhaled by thousands of children living in coastal areas. Additional exposure routes include
the ingestion of contaminated seafood and seawater. Epidemiologic studies of adults have linked
brevetoxin exposures to gastrointestinal inflammation, respiratory irritation, and neurological
problems. Because children have smaller body sizes, inhale more air, and consume more food
and water than adults, it is very likely they encounter higher doses of brevetoxin exposures. In
addition, protective bodily systems for detoxification are not fully developed, leaving children at
increased risk for brevetoxin-induced illnesses. However, no study to date has investigated the
impacts of brevetoxin exposures among children. Without epidemiologic data specific to this
population, scientific knowledge required for tailoring risk communication and public health
interventions remains incomplete, allowing any health risks to children to persist. To address this
critical gap, we are proposing the first population-based study of health effects from residential
brevetoxin exposures among children. Our interdisciplinary team is well-suited to conduct this
work given our complementary expertise in environmental epidemiology, pediatric health, emer-
gency medicine, and marine sciences. By spatiotemporally linking K. brevis monitoring data from
the Gulf of Mexico with emergency department records for children aged 0-18 years residing in
southwest Florida from 2012 through 2019, this work will leverage established resources to cost-
effectively assess residential brevetoxin exposures as a trigger for seeking emergency healthcare
and identify the bodily systems most affected. In addition, this work will produce maps of K.
brevis concentrations in Gulf waters by residential areas, providing a valuable resource for future
epidemiologic studies. Finally, the findings of this work will serve as a basis to improve
brevetoxin exposure assessment methods and design a prospective cohort focused on the health
effects of ocean-related exposures. Ultimately, the goal is for this project and related future
proposals is to catalyze research at the intersection of oceans and human health, fostering the
development of improved risk communication and policies to promote healthy lives.

Public health relevance
PROJECT NARRATIVE The proposed research addresses whether living near the coast during red tide events (caused by the algae K. brevis, which frequently grows out of control in the Gulf of Mexico and produces natural toxins) triggers emergency hospital visits among children. As the first ever epidemiologic study of residential brevetoxin exposures among children, this work will quantify short-term associations with emergency encounters overall and by discharge diagnoses. Such knowledge will be useful for characterizing the health effects of brevetoxin exposures among children, who are expected to be a sensitive population, and for improving public health guidance aimed at reducing the negative human health impacts of red tides.